EPIDEMIOLOGY OF DIABETES INTERVENTION AND COMPLICATIONS (EDIC)

This study is primarily an extended epidemiologic follow up investigation of the natural history of macrovascular disease in IDDM. This study takes advantage of an "intention-to-treat analysis" based on previous involvement of the study population with high intensity treatment with insulin in the DCCT.